Long-term Follow-up of the Systemic Immunosuppressive Therapy for Eye Diseases Cohort

Project Summary (Abstract)
Ocular inflammatory diseases are major causes of vision loss in the United States, occurring from
a relatively early age. Immunosuppression is a critical therapeutic approach for severe cases.
We previously collected data for 18,184 non-infectious ocular inflammation patients, which we
now propose to leverage in order to evaluate the critical question of whether immunosuppression
has a higher risk of death or death from cancer in the long run. We will do this by studying the
survival of these patients for an additional 11 years since their exposure to immunosuppressive
therapy (which will provide a median of >15 years’ follow-up for mortality risk following treatment).
Some of these drugs have been explicitly identified as carcinogenic in humans based
primarily on transplant data. We have not seen that effect in our research so far, but it is critical
to assure patients that the treatments are sufficiently safe to use, hence we are proposing to
extend this study. Since it also is important to understand which drugs are the most beneficial,
we also propose to follow-up our current work indicating that Tumor Necrosis Factor Inhibitor
(TNFi) drugs control inflammation better than “conventional” (and less expensive) treatment with
antimetabolite drugs (such as methotrexate). We propose to study whether TNFi therapy has
better visual acuity outcome and fewer ocular complications than single antimetabolite therapy;
whether TNFi therapy also is more effective in obtaining treatment success than combined, two-
drug conventional immunosuppression (an alternative, less costly approach); whether any of the
individual TNFi agents (infliximab, adalimumab and etanercept) are preferable in terms of
treatment success and; and how much cost is associated with these potential benefits of TNFi
therapy. We also propose to create tools to help doctors identify which patients are at high risk
of an unfavorable visual outcome, and to predict which patients will need higher (potentially more
toxic) doses of specific immunosuppressants, to help identify who needs stronger treatment from
the beginning. In addition, we aim to identify ophthalmic predictors of mortality, and whether
immunosuppression in fact reduces the risk of mortality for such patients as is assumed. We
further aim to estimate the incidence of and predictive factors for rhegmatogenous retinal
detachment in uveitis cases. The existence of this largest, purpose-collected United States ocular
inflammation database provides a unique opportunity to address many ocular questions of great
importance, with a high probability of successful execution.

Public health relevance
Project Narrative: Ocular inflammatory diseases, in aggregate, are a cause of visual impairment affecting people at an earlier stage of life than most blinding eye conditions. This study will evaluate the safety, benefit and costs of immunosuppression—the highest level treatment to avoid vision loss in ocular inflammation, and will develop tools to guide use of these immunosuppressive drugs. The study also will develop predictors to guide important other aspects of management for these patients, such as avoiding retinal detachment.